Structural and Functional Studies of the Uterine Lymphatics

PROGRAM SUMMARY
The uterus is a highly-fluid dynamic organ that experiences significant structural and physiological changes
throughout the estrus cycles, embryo implantation, pregnancy, and post-delivery. These phases are
characterized by rapid fluctuations in tissue fluid content and extensive vascular remodeling, which are optimally
designed for successful reproduction. Uterine lymphatics are thought to play key roles in managing uterine tissue
fluid homeostasis and regulating immune tolerance towards the fetus during pregnancy. Despite their crucial
roles in maintaining fluid balance and facilitating immune responses, the current understanding of the
development, structure, and function of the uterine lymphatics remains limited, especially when compared to the
well-studied uterine blood vessels. This project aims to gain a better understanding of the structure and function
of the uterine lymphatics, focusing on their growth and patterning, anatomical organization, remodeling, and
functional significance during pregnancy and non-pregnant states. Our research will not only shed light on the
development and function of the uterine lymphatics, but also offer wider perspectives on common uterine health
and disease challenges.

Public health relevance
PROJECT NARRATIVE The lymphatic system plays a vital role in regulating fluid balance and facilitating immune functions. The uterus, an organ that is exceptionally active in managing tissue fluid and immune reactions, experiences substantial transformations throughout the estrus cycles, conception, embryo implantation, pregnancy progression, and after birth. Our research focuses on examining the growth of uterine lymphatics and their functions in maintaining uterine tissue fluid balance and immune control during both pregnant and non-pregnant states.